PARTICIPATION IN CANCER AND LEUKEMIA GROUP B

This proposal requests continuation funding for institutional participation of the SUNY Health Science Center (Upstate Medical Center) Syracuse, New York, in the clinical research activities of Cancer and Leukemia Group B (CALGB). CALGB is a multi-institutional cooperative reserach group dedicated to the systematic planning, initiation, conduct analysis, and reporting of research as applied to therapy of patients with malignant disease. The scope of interest of CALGB and our institutional participation includes a wide variety of malignant disorders. The current CALGB proposal involves an increase in laboratory-based evaluations as well. The program in oncology at our institution in conjunction with CALGB is truly interdisciplinary, involving the active participation of Surgery, Radiotherapy, Clinical Pathology, Psychiatry, Pathology, Cytogenetics and Internal Medicine (Hematology and Medical Oncology). The Upstate Medical Center actively participates in all phases of the CALGB program. Our personnel contribute heavily to, and are prominent in, group scientific and administrative leadership, new study design and chairmanship, development and execution of pilot studies, the testing of new chemotherapeutic agents in phase I and phase II trials in addition to the accrual of greater than 150 patient entries/year to group protocols. The Leukemia Reference Laboratory for the entire group and the Committee Chairmanship in Lymphoma are located at our institution. As a result of the funding provided by this proposal and our institutional commitment, the accrual rate for patients entered into controlled, evaluable, experimental cancer therapy will be maintained at the current high level. The broadening and deepening of the clinical research program at our institution will similarly be reflected in the depth and breadth of our scientific and administrative involvement in CALGB activities. Since our institutional participation with CALGB is the core of the interdisciplinary cancer program at our institution, additional salutary effects will continue to be evident in the education of medical students, house officers, nursing staff as well as in the continuing education of physicians in mid-New York State. In addition, the collaboration with CALGB will help translate the most recent advances in medical care and expertise to a large and diversified patient population.